Mechanisms of APOE-Induced Preclinical Alzheimer's Pathophysiology in Human Olfactory System

Apolipoprotein E (APOE) is a major cholesterol carrier that supports lipid transport and injury repair in
the brain. In the CNS, APOE is mainly produced by astrocytes, and transports cholesterol to neurons via
APOE receptors, which are members of the low-density lipoprotein receptor (LDLR). However, during stress or
injury, neuronal production of APOE protein increases. APOE polymorphic alleles are the main genetic
determinants of late-onset Alzheimer disease (LOAD) risk: individuals carrying the ε4 allele are at increased
risk of LOAD compared to those carrying the more common ε3 allele, whereas the ε2 allele decreases risk.
Presence of the APOE ε4 allele is also associated with increased risk for cerebral amyloid angiopathy and age-
related cognitive decline during normal aging. Despite these findings, the mechanism by which APOE
specifically influences AD pathophysiology is poorly understood. Even more importantly, why APOE ε4 is
associated with LOAD in some people, but not in others remains unknown. Recently, we examined participant-
derived olfactory cells of APOE4 carriers compared to non-carriers and observed differentially higher
postmitotic (GAP43+)/mature (OMP+) densities, mitochondrial dysfunctions, cell deaths among aging cells of
ε4 compared non-ε4 isoforms. Importantly, while ε4 isoforms showed greater susceptibility to Aβ oligomer
(ABO)-induced injury, we observed that individual differences in the expression of DNA polβ (DNA repair gene)
moderated the impact of ABO on mitochondrial dysfunction, abnormal proteostasis and cell death. This is
consistent with our previous publication (Misiak et. al. 2017) demonstrating that haploinsufficency of DNA polβ
exacerbated mitochondrial dysfunction and cell death in AD mice. Therefore, we hypothesize that (1) APOE4
contributes to olfactory dysfunction in preclinical AD through aberrant neuronal differentiation, with resultant
susceptibility to greater mitochondrial and synaptic dysfunctions, DNA damages and neuronal death, as the
neurons advance in age and become exposed to increasing amount of toxins (e.g. Aβ); and (2) individual
differences in proficiency for DNA repairs contribute to individual differences on these neuronal outcomes.
We propose a 5-year prospective study to acquire olfactory cells through non-invasive sampling of 200
non-demented older (60-75 years; 100 ε4 and 100 non-ε4) adults with well characterized olfactory functions to
investigate molecular mechanisms underlying heterogeneity in severity of preclinical AD pathophysiologic
markers. Molecular studies in this proposal are a multimodal combination of transcriptomic, RNA-based
epigenomic, protein validation, mitochondrial profiling and enzymatic studies, aimed at uncovering novel
preclinical mechanisms. In Aim 1, we will investigate molecular mechanisms underlying APOE isoform-specific
effects on olfactory – (a) differentiation (b) neurite morphology and axonal outgrowth (c) whole-cell reactive
oxygen species (ROS) (d) mitochondrial function (e) synaptic protein levels and (f) proteostasis – across
cellular ages (DIV 7, 14 and 21). In Aim 2, we will examine the molecular mechanisms underlying
heterogeneous responses of each APOE isoform to ABO-induced stress exposures. In Aim 3, we will conduct
olfactory psychophysical and cognitive tasks on all participants annually to determine the influence of APOE4
status on both olfactory and cognitive trajectory over a 3-year follow-up. In view of 10% attrition rate, we will
target 250 enrollees. Finally, we will validate olfactory and molecular markers of APOE4 in olfactory cells of 40
mildly cognitively impaired (MCI) and AD individuals to determine which markers predict MCI or AD status.
Accomplishment of this study could result in the identification of pathophysiologic hallmarks at the earliest
phases of preclinical AD, which offers a unique opportunity for effective disease modification.

Public health relevance
Ethical constraint to repeated brain biopsies of cognitively normal living patients and the protracted long duration of asymptomatic preclinical phase of Alzheimer’s disease (AD) pose unprecedented challenge to efforts at elucidation of preclinical intraneuronal molecular hallmarks of AD progression. We propose use of olfactory neuronal isoforms derived non-invasively from non-demented older APOE4 carriers and non-carriers, with well-characterized olfactory functions to elucidate cellular, molecular and biochemical hallmarks of APOE4-related preclinical AD pathophysiology, predict cognitive trajectory with these intraneuronal pathophysiologic markers in a prospective phase, and examine the tenability of our novel concept that individual differences in DNA repair proficiency will largely explain the complexity (or heterogeneity) in the severity and progression of AD pathophysiology within APOE risk groups. Accomplishment of these aims could yield novel biomarkers to guide future development of disease-modifying therapeutics at potentially early reversible stages of AD.